Empowering Veterans to Self-Manage PTSD Symptoms Following Completion of Trauma-Focused Therapy

Background. Nearly 90% of Veterans who complete trauma-focused therapy (TFT) for PTSD have remaining
treatment needs. In the six-months following TFT, successful completers remain some of the highest utilizers
of VA mental health services despite clinically meaningful symptom improvement. Our prior work demonstrated
that Veterans who benefitted from TFT's primary post-TFT treatment needs were the practice and application
of skills learned during therapy, with the goal of maintaining or building upon treatment gains. Veterans
expressed low self-efficacy for meeting these goals without the support of their therapists and feared
stagnation or relapse without ongoing contact. As such, we developed and feasibility-tested a therapist-
assisted self-management program for TFT completers (EMPOWER) designed as a step down from active
psychotherapy. The feasibility open trial demonstrated that EMPOWER is feasible and highly acceptable to
patients. Further, findings suggest that the intervention was successful in helping Veterans maintain or
enhance PTSD-related gains while reducing their mental health service utilization. These promising findings
warrant a randomized evaluation. Significance. Interventions that meet Veterans' post-TFT treatment needs
are urgently needed. Mental health providers are delivering ongoing treatment to this high priority cohort of
Veterans without evidence to guide their treatment plan. Further, higher than expected levels of post-TFT
mental health care utilization threatens the continued implementation of these highly effective treatments. For
all Veterans to have access to the most effective treatments for PTSD, we must evaluate and implement
interventions that prepare and enable successful TFT completers to step down from active therapy.
Innovation. The proposed study is the first large-scale study of post-TFT care and the first to rigorously
evaluate a self-management program to step-down from active to maintenance mental health services
following a course of active psychotherapy. More broadly, we believe it to be the first intervention to directly
facilitate an episodic model of mental health care. Specific Aims: 1) Estimate posterior probability distributions
of EMPOWER's effects and establish likely ranges for those effects as compared to post-TFT TAU for
Veterans' MH service utilization and self-reported PTSD symptoms. The subsequent Hybrid RCT will be
designed after assessing the likelihood of detecting an effect for EMPOWER across a range of sample sizes
using Go/No Go and Overall Power methods. 2) Explore the impact of EMPOWER compared to post-TFT TAU
on Veterans'(a) self-efficacy for managing PTSD symptoms, (b) satisfaction with post-TFT care, (c) well-being
& functioning (d) depression, and (e) secondary utilization outcomes. 3) Conduct semi-structured interviews
with Veterans and providers to contextualize quantitative findings and identify potential barriers, facilitators,
and strategies to facilitate future implementation of EMPOWER. Methodology: We are proposing a pragmatic
randomized control trial (RCT) in which 36 PE and CPT providers will be randomized to support Veterans as
they participate in the EMPOWER self-management program or facilitate TAU. Participants will be patients of
the study providers who recently completed a course of PE/CPT during which they experienced clinically
meaningful reductions in PTSD symptoms (n=90). Primary outcomes will be mental health service utilization
(overall and with PE/CPT providers) and self-reported PTSD symptoms measured four times over a 9-month
period. Qualitative interviews with providers (n=18) and Veterans (n=24) focused on providers' impressions of
treatment effectiveness, implementation challenges/potential strategies, and Veterans' perception of treatment
effectiveness. Next Steps: With partners at the National Center for PTSD and the Office of Mental Health &
Suicide Prevention, we will determine whether a subsequent Hybrid Type I or II RCT is warranted.

Public health relevance
Patients who complete prolonged exposure and cognitive processing therapy, the treatments for posttraumatic stress disorder (PTSD) with the most empirical support, continue to express a need for mental health treatment. A therapist-assisted self-management program for patients who have completed one of these two treatments and achieved symptom improvement has the potential to meet patients' stated treatment needs, maintain or build upon their PTSD symptom reductions, increase their confidence in managing their symptoms, and reduce the number of mental health appointments that they need to attend. Further, reducing the number of mental health sessions attended by completers of these time and resource intensive psychotherapies will increase the likelihood that their implementation in regular-practice clinics will be maintained.